Development of tools for site-directed analysis of gene function

The goals of our R24 project include producing new revertible alleles to identify genes capable of promoting human health and generating new methodologies for site-­directed somatic mutagenesis, enhancing homologous recombination and single-­strand annealing mediated integration of DNA. It is anticipated that these technologies will greatly alleviate the number of animals required for genetic studies in zebrafish and can be extended to other animal species. The success of this technology development hinges on the ability to screen embryos and larvae for fluorescent reports of gene expression and transgenesis. In this R24 revision, we are proposing to increase our optical sectioning abilities and update existing fluorescence microscopes to meet the increased demands on our imaging equipment that is a critical part of our experimental strategies and those of other groups at Iowa State University (ISU). These goals will be accomplished in the following aims: Aim 1. Improve optical sectioning capabilities of living zebrafish embryos at Iowa State. We are proposing to purchase a Zeiss AxioImager Z2 equipped with an Apotome 2 to meet the increased optical sectioning demands at ISU. Aim 2. Update existing microscopes used in association with our zebrafish facilities with LED light sources. Together, the updates proposed above would greatly increase our fluorescence screening and imaging needs of our currently funded R24 project, our colleagues at ISU, and future initiatives.

Public health relevance
The goals of our R24 project are to test new revertible alleles to identify genes capable of promoting human health, to develop new methodologies for site- directed somatic mutagenesis, and to enhance homologous recombination and single- strand annealing mediated integration of DNA in zebrafish. Using fluorescence to identify founders will greatly reduce the number of zebrafish needed to conduct gene targeting experiments. In this revision, we request funding for state- of- the art microscope equipment to enhance our fluorescence screening and imaging capabilities and successfully achieve the goals of our project.